BRAIN TISSUE TRANSPLANTATION IN PRIMATES

To advance the work already performed in our laboratory with rats, fetal substantia nigra or adrenal medulla was grafted to the denervated caudate of the rhesus monkey in our continuing research on brain tissue transplantation. Although only moderately successful thus far, the experiments have demonstrated for the first time that peripheral tissue autografts can survive transplantation into nonhuman primate central nervous system.